Mechanisms and Correction of Abnormal Bicarbonate Secretion by DRA in Diarrhea

SUMMARY
There remain major gaps in understanding regulation of human intestinal electrolyte transport under normal
physiologic conditions and in diarrheal diseases. This proposal deals with the role of the brush border (BB)
Cl/HCO3 antiporter, SLC26A3 (DRA) in intestinal Na, Cl and HCO3 transport and will resolve the gap in
understanding of its acute regulation, intestinal cells involved and ways to reverse the abnormal transport in
severe, cAMP related diarrheas. The long term goal of this project is to define the coordinated and dynamic
changes in Na, Cl and HCO3 transport that occur in diarrhea so that they can be targeted by drugs to reverse
the changes and treat most diarrheal diseases. The Aims of this proposal include to: I.Test the hypothesis
that necessary steps in cAMP/cholera toxin inhibition of neutral Na and Cl absorption that involves DRA, which
occurs at the same time as stimulation of DRA activity and the related HCO3 secretion, includes increased
trafficking of DRA to the BB and reduction in the physical association of DRA with NHE3 that occurs under
basal conditions and increased physical association with CFTR. II. Test the hypothesis that cAMP related
changes in DRA and NHE3 activities and trafficking involve association with SNX27 in early endosomes and
these changes can be reversed by retromer stabilizers, which identify a new drug target to treat diarrhea. To
accomplish these studies we will use ileal and proximal colonic enteroids made from healthy human subjects
grown as 2D monolayers and compare the results with those from the human colon cancer cell line, Caco-2
cells. Caco-2 cells are used for many studies of intestinal physiology and for drug development, including anti-
diarrheal drugs. We predict that Caco-2 cells will give similar information regarding intestinal Na, Cl and HCO3
transport under basal conditions and in models of diarrhea; however it will be important to identify any
differences that could be relevant to studies of intestinal function and drug development. These studies are
innovative being among the first to study electrolyte transport in human enteroids as monolayers, to examine
the interaction of DRA with NHE3 and CFTR in the same cell population with emphasis on their dynamic
interactions with each other under basal conditions and with elevated cAMP, are the initial study of the role of
the early endosomal protein SNX27 and the retromer in acute DRA regulation, and develop studies of
SNX27/retromer as a potential drug target for future development to treat diarrhea. The expected outcomes of
this proposal will be to a) understand the coordinated regulation of DRA, NHE3, and CFTR in a model of
severe diarrhea that includes consideration of mechanism of HCO3 loss, a gap in understanding the
pathophysiology of diarrhea, b) establish that drug therapy of diarrhea must consider the coordinated
regulation of DRA with NHE3 and CFTR and not just the regulation of each transporter alone, and c) identify a
new drug target in a diarrhea model in human intestine that can reverse the diarrhea related transport changes
in DRA and NHE3, and that potentially could be developed into a drug to treat diarrhea.

Public health relevance
NARRATIVE The proposed research is relevant to public health because it will fill in a major gap by identifying new aspects of the pathophysiology of diarrhea and identify a potential new drug target for treating diarrhea (SNX27-retromer). Human enteroids (intestinal stem cell derived “mini-intestines”) made from normal ileum and proximal colon will be compared to results in the polarized human colon cancer cell line Caco-2 in studies examining how a severe model diarrhea (cAMP/cholera toxin) alters intestinal Na, Cl and HCO3 transport, with emphasis on the brush border Cl/HCO3 exchanger SLC26A3 (DRA) by a process that includes changes in its trafficking to the brush border of intestinal cells, reduction in its physical association with NHE3 and increase in its association with CFTR. Comparison of the two models, human enteroids and Caco-2 cells, will inform the fields of intestinal transport and drug development as to whether the models can be interchanged or further studies are warranted to determine which model more closely mimics what occurs in normal human intestine.